Pyruvate oxidase: a molecular determinant of commensalism among the oral microbiome

Project Summary
Caries is one of the most prevalent oral diseases. Despite several decades of substantial caries
research, only incremental progress has been made in disease prevention. Caries is the result of
polymicrobial dysbiosis and not curable since the tooth structure is destroyed by fermentative acid
by-products from caries-associated bacterial species. Therefore, strong emphasis should be on
caries prevention. Caries risk assessment (CRA) is a widely accepted approach to caries
prevention, but has been criticized because it leads to patients with increased risk not being
identified. One drawback of CRA is that the polymicrobial nature of caries is not considered.
Furthermore, it lacks any molecular markers sampled directly at the tooth surface where caries
occurs. A key to improved CRA and prevention is a better understanding of molecular
mechanisms that promote oral commensals associated with general oral health. We have
identified an important trait of commensal oral streptococci that promotes molecular
commensalism: the pyruvate oxidase, SpxB, provides a growth advantage under aerobic
conditions since its metabolic activity generates additional ATP as well as pathogen-inhibiting
H2O2. SpxB therefore enables early commensal streptococci to outgrow and inhibit
H2O2 susceptible and caries-associated species. Our hypothesis is that commensal streptococci
producing higher amounts of metabolically important ATP and inhibitory H2O2 are more
competitive and thus allow dental plaque to be more resistant to cariogenic dysbiosis. We
therefore propose the following Specific Aims:
Aim 1: Cellular context - molecular mechanisms determining differential H2O2 production.
Aim 2: Oral context - determine whether spxB regulation influences competitiveness in vivo.
Aim 3: Clinical context - Real time measurements of H2O2 production and spxB expression
from ex vivo dental plaques.
The proposed aims will support our overall goal to better understand the health-associated traits
of oral commensals and lead to a paradigm shift in caries research towards that of molecular
commensalism; a vastly understudied area of oral microbiology. The gained
knowledge will provide important new insight into the development of new strategies to prevent
oral diseases like caries.

Public health relevance
Dental caries is one of the most prevalent dysbiotic diseases worldwide. Since caries itself is irreversible, focus should be on caries prevention. This study aims to understand the role of commensal streptococci in promoting oral health. Specifically, we will identify how a common molecular trait of commensal streptococci, the production of H202 by the pyruvate oxidase, can be used as predictor of caries risk before caries manifestation.